Training in Cardiovascular Research

Project Summary
The T32-funded Cardiovascular Training Program at UT Southwestern has a long and illustrious history
of fostering emergence of capable and productive investigators ideally positioned for independence and success.
Indeed, our Program has an impressive track record, producing a large number of capable researchers who
continue to have substantial impact. Over this period, our institution and the Division of Cardiology have evolved
from a research emphasis heavily weighted towards basic science to one that now includes broad strength and
representation in translational science, clinical trials, population-based research, and health services and
outcomes research.
Four years ago, we completely revamped our T32 Training Program, shrinking its size, limiting it to
postdoctoral trainees, sharpening the focus of our oversight and management, and becoming more “data driven”
in evaluating our trainees and our Program.
Now, 4 years later, we can say that the transition has been a huge success. Our trainees are now
uncommonly productive in their research endeavors. The program is evenly balanced between basic and
clinical/translational research. Our program is now reflective of a) the growth of highly successful programs in
clinical and translational cardiovascular research at UT Southwestern over the past decade, b) our goal to
prepare the best investigators across the full spectrum of cardiovascular research, and c) the reality of the current
funding environment for basic research. Importantly, this shift in focus allowed us to better recruit MD
investigators who are co-enrolled in clinical training programs. Of note, the Internal Medicine Residency and
Cardiology Fellowships at UT Southwestern are among the strongest in the country.
Our Cardiovascular Training Program is just that, a training program, and not a funding mechanism. Our
primary objective is to develop the next generation of transformative cardiovascular investigators by recruiting
highly talented and motivated individuals and preparing them for success in an increasingly competitive and
resource-challenged environment. A secondary objective is to expand the cadre of women and minorities
pursuing careers in cardiovascular research. Our faculty is diverse, spanning a spectrum of expertise from
molecule to cell, organ system, organism, and population. Members of our faculty are distributed across the full
spectrum of faculty rank, gender, and ethnic background.
In summary, our Program is designed to foster the emergence of the next generation of investigators,
teachers, and mentors at a time when the need for such has never been greater.

Public health relevance
PROJECT NARRATIVE The need for new discoveries in cardiovascular medicine has never been greater. To address this urgent issue, we are training the next generation of rigorously prepared cardiovascular investigators, both scientists and physicians. We provide a comprehensive program of education, mentoring, oversight, and feedback designed explicitly to help meet the cardiovascular healthcare needs of the future.